The function of the PRMT5 methylosome in MTAP deleted cancers

PROJECT SUMMARY
The methylthioadenosine phosphorylase gene (MTAP) is frequently co-deleted with CDKN2A, occurring in
25-50% of cancers of the pancreas, esophagus, and lung. We discovered that MTAP deletion leads to selective
dependency of cancer cells on PRMT5, a discovery that led to multiple therapeutic programs. MTAP loss leads
to high levels of its substrate methylthioadenosine (MTA), which competes with S-adenosylmethionine (SAM),
thus acting as a specific inhibitor of PRMT5. We first proposed that MTA-cooperative PRMT5 inhibitors (MTAC-
P5i’s) would be needed to exploit this synthetic lethality. New MTAC-P5i’s are showing significant tumor
responses in MTAP/CDKN2A-deleted cancers in phase I clinical trials, and MTAC-P5i’s are well-tolerated without
evidence of myelosuppression. This proposal will build on strong preliminary data and will leverage state-of-the-
art technologies and model systems to define mechanisms of tumor cell-intrinsic and -extrinsic sensitivity and
resistance to MTAC-P5i therapy, ultimately informing combination therapy strategies to advance in clinical trials.
Despite promising early clinical data with MTAC-P5i’s, resistance emerges and will require new therapeutic
combinations. In Aim 1, we will deploy novel functional genomic approaches, including a dual-targeting CRISPR
library disrupting single genes and closely related paralog pairs, to define the tumor cell-intrinsic mechanisms of
sensitivity and resistance to MTAC-P5i. We will discover genetic and therapeutic perturbations that augment or
blunt response to MTAC-P5i’s. We will also conduct in vivo validation studies testing MRTX1719 combinations,
furthering the validation of our preliminary work with RAS pathway inhibitors and expanding to include CDK4/6
or MAT2A inhibitors. Lastly, we will investigate genetic mechanisms of acquired resistance to MTAC-P5i’s
through genomic characterization of in vivo PDX models.
MTAP-deletion also results in the excretion of the metabolite MTA into the tumor microenvironment (TME).
MTA is known to mediate an immunosuppressive effect; however, the full impact of MTA on cellular components
of the TME and its implications for combination therapy remain unknown. In Aim 2, we will dissect the role of
MTA and MTAC-P5i in remodeling the TME and examine combinations of MTAC-P5i and RAS pathway inhibitors
in using novel Mtap-deficient immunocompetent orthotopic transplant models of pancreatic ductal
adenocarcinoma (PDAC). We will utilize multi-modal approaches to elucidate the impact of MTAP deletion and
MTAC-P5i’s on the TME. We will also leverage these models to examine the combinatorial efficacy of MTAC-
P5i with KRASG12D or B/CRAF inhibition and immune checkpoint blockade. Lastly, we will use in vitro isogenic
model systems to examine the influence of MTA and MTAC-P5i on T-cell viability and activity. Collectively, these
studies will address challenges to improve the efficacy of MTAC-P5i therapy, including defining mechanisms of
resistance, elucidating the role of MTA and MTAC-P5i in remodeling the TME, and credentialing top combination
therapy strategies, with the eventual goal of informing next-generation clinical trial development for patients.

Public health relevance
Project Narrative Based on our discoveries, a new set of cancer therapeutics are entering clinical trials targeting the PRMT5 protein in solid tumors missing the MTAP gene. In our first aim, we seek to understand the mechanisms that will enhance sensitivity or create resistance to these drugs and develop combination therapeutic regimens for treating lung and pancreas cancers based on our insights. In our second aim, we investigate how these treatments affect the surrounding tumor and immune environment.